Evaluation of the Mechanisms Underlying Induction and Maintenance Immunosuppression Impact on T Cell Function after Kidney Transplantation

Abstract
Antithymocyte globulin (ATG) is a lymphodepleting induction immunosuppression used in approximately 30%
of all kidney transplants, associated with decreased rates of rejection but increased rates of infection after
kidney transplantation (KTx). Despite many years of use, the mechanism of action behind the observation
remains unknown. A current unmet need in the field of transplantation, therefore, is understanding the impact
of ATG induction and the concomitant maintenance immunosuppression medications to guide candidate
selection and post-transplant management of immunosuppression. Our R21-derived data demonstrated an
association between epigenetic changes in PBMC and incidence of infection after kidney transplantation. We
have additionally observed that ATG causes a distinct impact on differential methylation at regions related to T
cell differentiation and activation using bulk DNA methylation approaches, and that ATG and differentially
impacts CD4 memory T cells, CD8 terminally differentiated T cells, and senescent T cells compared with non-
ATG induction. However, we lack information at the single cell level relating to epigenetic, transcriptional, and
immune phenotype changes. We also lack information regarding the longitudinal relationship of epigenetic and
transcriptional changes and the impact of ATG on T cell function and T cell receptor (TCR) repertoire.
We hypothesize that ATG, compared with non-ATG induction, will alter the epigenetic and transcriptional
landscape after KTx, and that these changes will be associated with significant differences in immune
phenotype, with expansion of memory CD4 and senescent CD8 T cells. Using a single cell analysis approach,
we will analyze regions of differential chromatin accessibility and gene expression as well as cell surface
proteins to determine the mechanism impact of ATG and maintenance immunosuppression. We hypothesize
that ATG will change T cell phenotype and function measured by cytokine secretion in response to clinically
relevant infectious antigens and decrease TCR repertoire post-KTx, compared with patients receiving non-ATG
induction. We will test this hypothesis using antigen stimulation and measure cytokine release and TCR
repertoire in the ATG versus non-ATG group. Our overarching goal is to understand the mechanism behind
ATG-driven epigenetic changes on T cells by quantifying alterations to the epigenome and transcriptome in
parallel with evaluating measures of T cell function. Defining mechanisms at a molecular level will provide
insight for development of tools for candidate selection and patient risk stratification. We will take advantage of
biobanked specimens of pre- and post- KTx patients in a cohort with previously collected outcome data at a
granular level, including demographic and clinical details. We will develop a comprehensive understanding of
how immunosuppresion impacts epigenetic and transcriptional regulation of T cell function, a crucial
component of the immune system controlling development of infection. Ultimately, this information can be
applied to guide immunosuppression and improve patient outcomes after KTx.

Public health relevance
Project Narrative Kidney transplant recipients are at risk for developing severe infection after transplantation, which is increased almost twofold if they receive induction immunosuppression with antithymocyte globulin (ATG) a medication which is used to decrease rates of rejection after solid organ transplantation. We propose to evaluate the impact of ATG induction and maintenance immunosuppression to determine the mechanism of impact by measuring epigenetic, transcriptional, and cell surface changes in parallel with studies in T cell phenotype, function, and T cell receptor diversity. Reaching a better understanding of the mechanism behind these anti- rejection drugs could improve our ability to select patients who would benefit from ATG and to better individualize immune suppression to reduce incidence of infection without increasing rates of rejection, and especially important goal for the growing numbers of older transplant candidates with end stage kidney disease who require transplantation.